A novel mitotic regulatory axis in neuroendocrine prostate cancer

Neuroendocrine prostate cancer (NEPC) is a lethal subset of metastatic castration-resistant prostate cancer
(mCRPC) with aggressive clinical features and poor overall survival. Although rarely occurs de novo, the
treatment-related NEPC (t-NEPC) derived from prostatic adenocarcinoma (PAC) can arise in about 25% or more
late stage mCRPC, which is notoriously hard to treat and resistant to antiandrogen therapy. There is an urgent
need for novel targets and therapies. In this study, we seek to determine the roles of PKD in t-NEPC and exploit
the therapeutic potential of PKD inhibitors for the treatment of t-NEPC. PRKDs were amplified and/or upregulated
in nearly 60% of NEPC tumors. PKD, particularly PKD2, protein expression and activity were elevated in NEPC
tumor tissues. Knockdown of PKD2/3, the predominant PKDs in NEPC cells, decreased NE biomarkers, inhibited
cell proliferation/survival, and tumor growth in vivo, while PKD2 overexpression promoted NE programing by
inducing NE markers and suppressing AR-targeted genes, which paralleled the effects of N-myc, a major driver
of NEPC. Overexpression of PKD2 also conferred androgen independence and reduced sensitivity to
chemotherapeutic agents in in androgen-sensitive PAC cells. We further identified AURKA/Aurora-A kinase as
a novel downstream target of PKD. Aurora-A, a key mitotic regulator that is co-amplified and upregulated with
N-myc in NEPC tumors, promotes NEPC progression by binding and stabilizing N-myc. Our data indicated that
PKD activity was required for the stabilization of Aurora-A/N-myc complex. Overexpression of PKD phenocopied,
while knockdown of PKD blocked, the functions of N-myc in prostate cancer cells, implying a role of PKD in
regulating Aurora-A/N-myc complex. Moreover, the stabilization of Aurora-A by PKD is necessary for mitotic
entry, a function that may contribute to taxane-based therapy resistance. Importantly, inhibition of PKD by the
PKD inhibitor CRT0066101 (CRT) blocked NEPC tumor cell proliferation/survival, migration/invasion, and
suppressed the growth of NEPC tumor xenografts and reduced bone metastasis in vivo. CRT also synergized
with docetaxel and PI3K inhibitor in NEPC cells, implying their potential use in combination therapy. Based on
these findings, we hypothesize that increased PKD expression and activity promote mitotic programing
and Aurora-A/N-myc complex stability to impinge upon N- myc-driven t-NEPC progression. We further
posit that PKD inhibitors will derive a new therapeutic strategy to better treat NEPC. We propose to: Aim
1. Determine PKD as a potential biomarker for t-NEPC and assess the functional relevance of PKD-activated
mitotic programing to therapeutic resistance in t-NEPC. Aim 2. Test the hypothesis that PKD promotes t-NEPC
by stabilizing Aurora-A/N-myc complex to impinge upon N-myc-driven oncogenesis. Aim 3. Determine the
therapeutic potential of PKD inhibitors for treatment of NEPC in a metastatic NEPC mouse model and TRAMP
mice.

Public health relevance
Prostate cancer is the second leading cause cancer-related death among American men. Androgen deprivation therapy has been the standard therapy for advanced metastatic prostate cancer. Although it leads to favorable response initially, virtually all patients will eventually become castration-resistant. The development of therapeutic resistance is in part due to the emergence of treatment-related neuroendocrine prostate cancer which is clonally derived from prostate adenocarcinoma through neuroendocrine differentiation, a process involving induction of neuroendocrine markers and loss of AR and AR signaling activity. Our preliminary data demonstrates a novel functional link between PKD and neuroendocrine differentiation, and demonstrating a potential role of PKD in the pathogenesis of treatment-related NEPC through modulating mitotic programing and the expression of Aurora-A kinase to impinge upon N-Myc-driven NEPC progression. We further posit that PKD SMIs will derive a new therapeutic strategy to better treat NEPC. The successful completion of this study will define PKD as a novel potential target for NEPC and provide mechanistic understanding of treatment-induced prostate tumor progression to therapy resistance.